Exercise-Induced Shear Stress Modulates Metabolic Pathways for Vascular Repair and Protection

Exercise-Induced Shear Stress Modulates Metabolic Pathways for Vascular Repair and Protection
Cardiovascular and metabolic diseases are on the rise in our veterans returning from battlefields in
Afghanistan and the Middle East, and exercise intervention remains an effective lifestyle modification.
Hemodynamic stress forces modulate both metabolic and mechanical effects on vascular endothelial cells,
mediating the focal and eccentric nature of atherosclerotic lesions. The advent in metabolomics and metabolic
profiling has led to the discovery of new metabolic biomarkers and therapeutic targets. We established that
bidirectional oscillatory flow impairs autophagic flux, perturbing mitochondrial homeostasis. In contrast,
unidirectional pulsatile flow attenuated mitochondrial DNA damage to maintain endothelial homeostasis. In
parallel, we developed flexible micro-electrochemical impedance sensors for detection of metabolically active
atherosclerotic lesions in the New Zealand White (NZW) rabbit model. We demonstrated that oxidized Low-
Density Lipoprotein (oxLDL) in atherosclerotic lesions display distinct frequency-dependent electrical and
dielectrical properties. Our preliminary studies revealed that pulsatile and oscillatory flow differentially
modulated metabolic pathways to promote vascular regeneration and athero-protection. We demonstrated that
flow-sensitive arterial metabolic changes were detected by electrochemical impedance spectroscopy (EIS).
Furthermore, our metabolomics analyses revealed that PSS vs. OSS differentially activates PKCɛ-6-
phosphofructo-2-kinase/fructose-2,6-biphosphatase 3 (PFKFB3) signaling to increase glycolytic metabolites,
but to decrease gluconeogenic metabolites, for vascular repair and regeneration. Metabolomics analyses
further uncovered flow-sensitive nuclear hormone receptor peroxisome proliferator-activated receptor 
(PPAR)-dependent fatty acid metabolites to mitigate monocyte recruitment. In this context, we hypothesize
that exercise-augmented pulsatile shear stress (PSS) modulates glycolytic and lipid metabolic
pathways to influence vascular regeneration and protection, leading to the arterial metabolic changes
that can be detected by 3-D EIS mapping. To test our hypothesis, we have three aims. In Aim 1, we will
determine if flow-mediated PKCε signaling modulates glycolytic metabolites for vascular regeneration. We
hypothesize that PSS and OSS differentially modulate PKCε-PFKFB3 signaling pathway to regulate production
of glycolytic metabolites. In Aim 2, we will determine if flow-sensitive PPAR signaling modulates lipid
metabolites for vascular protection. We hypothesize that PSS and OSS differentially modulate PPAR-SCD-1
signaling to regulate production of fatty acid metabolites. In Aim 3, we will demonstrate shear stress-PPAR-
mediated arterial metabolic changes by 3-D EIS mapping. We hypothesize that PPAR-SCD1-mediated
metabolic changes can be interrogated by 3-D EIS mapping. Overall, the integration of vascular biology,
hemodynamic forces and metabolomic profiling will provide metabolic insights into flow modulation of glycolytic
and lipid metabolisms to discover new biomarkers with therapeutic implications for our veterans at risk for heart
disease and metabolic syndromes.

Public health relevance
Project Narrative Cardiovascular disease and metabolic syndromes are the rising health risk factor to our returning Gulf War and Afghanistan Veterans. Exercise-mediated hemodynamic forces impart both metabolic and mechanical effects to initiate atherosclerosis. While elucidating vascular metabolomic profiles in reponse to pulstile vs. disturbed flow uncovers metabolic biomarkers and therapeutic targets, developing 3-D electrochemical impedance sensors provides new insights into detecting arterial metabolic changes in response to hemodynamic forces.